Reprogramming of myelopoiesis by DNMT3A mutation in lung cancer

PROJECT SUMMARY/ABSTRACT
The past decade has witnessed groundbreaking work associating clonal hematopoiesis (CH), where acquired
mutations define clonal outgrowths of hematopoietic stem cells, with chronic inflammatory diseases including
solid cancers. While we have begun to understand suppressive mechanisms that hinder antitumor immunity, it
remains unclear how immune cells in the tumor microenvironment behave differently when originating from
progenitors carrying CH mutations like DNMT3A. Recent studies have established myeloid-biased
hematopoiesis in the context of both DNMT3A CH and cancer-induced emergency myelopoiesis.
Mechanistically, our laboratory has suggested the ability of lung tumors to communicate with distal bone
marrow niches, pushing immune progenitors to produce corrupted progeny. Furthermore, recent work has
shown that tumors can epigenetically rewire myeloid progenitors to increase production of immunosuppressive
macrophages and interfere with tumor control. Expanding on these studies, I hypothesize that hematopoietic
progenitors are molecularly reprogrammed by CH-related DNMT3A, increasing myeloid-driven
immunosuppression, and enhancing bone marrow dysfunction in response to tumor-associated inflammation.
Aim 1 will characterize the epigenetic wound inflicted by lung adenocarcinoma through a cohort of
progenitor-enriched peripheral blood samples from lung cancer patients with DNMT3A CH. Using integrated
single-cell multiomics and genotyping, I will trace molecular changes driven by DNMT3A mutation along the
lineage of immune hematopoietic progenitors to circulating monocytes. I will assess the contribution of
uncovered pathways to driving inflammatory phenotypes in DNMT3A mutated cell line experiments.
Aim 2 extends the investigation to the lung tumors of DNMT3A CH patients, through spatial transcriptomics
and genotyping. Spatial methods do not require tissue dissociation, which enables localization of both tumor
myeloid cells arising from DNMT3A-mutated hematopoietic progenitors and wildtype cells. Genome-wide
transcriptomic readouts will capture the full effects of enhanced immunoregulatory signaling and
CH-associated inflammation on tumor immune responses. I will use co-cultures of lung cancer spheroids and
myeloid cells as a simplified tumor microenvironment model to interrogate spatial transcriptomic findings.
Together, these aims will identify CH-associated molecular programs in hematopoietic progenitors which may
serve as novel neoadjuvant targets in patients refractory to conventional therapy. Leveraging the excellent
training environment at Mount Sinai, this proposal bridges computational analyses, biological discovery, and
clinical potential, serving as a well-rounded foundation for my career as an academic hematologist/oncologist.

Public health relevance
PROJECT NARRATIVE The presence of age-associated mutations in hematopoietic stem cells, which give rise to all immune cells, has been strongly associated with poorer outcomes in numerous chronic diseases including lung cancer. As the second most lethal malignancy worldwide, lung cancer evades and alters the immune system in countless ways, leading to diminished tumor-clearing responses. This interdisciplinary proposal will examine how age-associated mutations in hematopoietic cells further impair immune cell responses to lung cancer, which will help define blood-based biomarkers that predict resistance to cancer treatments and form the basis for targeted therapeutics with greater response rates.